PHYSIOLOGICAL ANALYSIS OF VOLUNTARY MOVEMENT

Studies of voluntary movement focused on the role of the cerebellum. One issue was the contribution of the cerebellum to coordination. The results seem to indicate that the cerebellum is critical for the coordination of multijoint movement. One role of the cerebellum appears to be in the control of force. A second issue is the role of the cerebellum in motor learning. In tasks of motor learning, it has been demonstrated that patients with cerebellar disturbances have difficulty with procedural visuomotor learning. Patients with Parkinson's disease (PD) had normal procedural learning. A third issue is the role of the cerebellum in the sense of movement. Results so far show a deficit in appreciating the size of movements in patients with cerebellar deficits. Using O-15 labelled water as a marker for cerebral blood flow in positron emission tomography (PET) studies, we have been working on methods for improved anatomic correlation of regions of metabolic change by superimposing the PET image onto an MRI image. Regions of the brain activated with voluntary movement and vibration of the hand have been identified and quantified. Special attention is being paid to the topography of activation in different parts of the brain including the cerebellum. A special study was devoted to the role of the cerebellum in learning of a sequence of finger movements. Studies of movement-related cortical potentials have focused on identifying dipoles for the generation of the different components and the development of techniques for measuring event-related desynchronization of the EEG. The dipoles have been compared with areas of activation with PET and an excellent correlation has been found, Studies have been completed in patients with dystonia that show reduction in amplitude of some components. Studies in the Biomechanics Laboratory of the Department of Rehabilitation Medicine have focused on the control of balance and gait. A study is in progress of gait in patients with cerebellar disorders. Other studies are being done of balance in patients with cerebellar deficits. New studies have been initiated in recording muscle spindle activity during voluntary movement.